Emergent Multi-Cellular Properties Regulating Pancreatic Islet Function

Diabetes is caused by insufficient secretion of insulin and subsequent loss of glucose homeostasis
as a result of dysfunction or death of insulin-secreting β-cells. β-cells within the
islet do not function autonomously: extensive interactions occur between β-cells and with other
endocrine cells that control the regulation of insulin secretion. Previously, we and others
established a critical role for gap-junction mediated electrical communication
between β-cells that coordinates the dynamics of electrical activity, Ca² elevations and insulin
release. β-cells are functionally heterogenous, yet the way in which different populations of
β-cells influence the function of the whole islet is poorly understood. As such, the
overall goal of our research program is to understand how islet function is determined
by coupling between the diverse populations of β-cells. In the previous funding period, we
discovered and characterized distinct sub-populations of β-cells within the intact islet, that can
influence the dynamics and glucose sensitivity of whole islet electrical activity. However critical
gaps in our understanding remain. This includes how functional sub-populations impact both first
phase and second phase dynamics of insulin secretion; the presence and role of functional
sub-populations in human islets; and how changes in sub-populations in diabetes impact islet
function. To address these open questions, we have designed 3 specific aims to test our overall
hypothesis: that populations of β-cells with distinct functional characteristics exert
disproportionate control over multiple aspects of the islet Ca² response, via electrical
coupling. 1) Characterize how β-cell sub-populations coordinate the initial first-phase
response of the islet following glucose elevation; 2) Characterize the presence of
functional sub-populations and electrical communication in human islets insitu; 3) Determine the
gap junction dependence for functional sub-populations under healthy conditions and in type2
diabetes. By understanding how heterogenous β-cell populations within the islet interact, we will
gain fundamental understanding how islet electrical and insulin secretion response is regulated.
Thus, therapeutic targets which may disproportionately influence a certain β-cell
population may provide new ways to control the islet under pathogenic conditions.

Public health relevance
Failure of the islets of Langerhans leads to diabetes as a result of insufficient insulin release. Cells within the islet are highly variable and show extensive crosstalk, yet how this variability affects the way the islet releases insulin is poorly understood. A precise understanding of these factors, including within human islets, will provide information as to how the islet can become dysfunctional in diabetes, thus identify drug targets for preventative treatments.